Combinatorial cytokine-coated macrophages for targeted immunomodulation in acute lung injury

PROJECT SUMMARY
Acute lung injury (ALI) and its severe form, acute respiratory distress syndrome (ARDS), is a life-
threatening disease that develops because of viral/bacterial infections (e.g. COVID-19), trauma, sepsis,
pneumonia, or transfusion. ALI/ARDS remains a significant health burden in the United States with a high
incidence and mortality rate (30-40%). Past interventional studies have mainly centered around early-stage
supportive care such as ventilation which has limited utility. Despite several investigations, no effective
pharmacological therapy exists for the treatment of ALI/ARDS. Mechanistically, ALI/ARDS is caused by the long-
lasting activation of macrophages and infiltration of neutrophils due to their phenotypic shift towards the pro-
inflammatory status. In the absence of ALI, alveolar macrophages (AMɸ) exist primarily in the anti-inflammatory
phenotype, assisting in constructive processes. Upon sensing pathogens, AMɸ takes on an pro-inflammatory
phenotype that secretes high levels of pro-inflammatory cytokines which can lead to an uncontrolled cytokine
storm. We hypothesize that the acute pulmonary inflammation can be resolved by reprogramming macrophages
by novel pharmacotherapies for effective treatment of ALI. Driven by this hypothesis, the goal of this project is
to engineer an innovative macrophage-based pharmacotherapy (MEAT) for targeted immunomodulation in ALI.
MEAT integrates macrophages’ inflammation targeting and therapeutic capabilities for ALI immune environment
modulation. MEAT is composed of macrophages coated with a biomaterial that carries a pair of synergistic
cytokines which can exert potent effects in programing macrophages and neutrophils to the anti-inflammatory
phenotype. Two independent specific aims have been planned. In Aim 1, we will develop, optimize, and
characterize MEAT capable of programming macrophages and neutrophils toward anti-inflammatory phenotypes
in vitro. In this aim, we will determine the concentration-, ratio-, and temporal-requirements for optimal
combination of IL-4 and IL-10 to program macrophages and neutrophils. We will then assemble and optimize
MEAT to recapitulate these requirements for optimal macrophage and neutrophil modulation in vitro. In Aim 2,
we will evaluate the efficacy of MEAT in resolving acute inflammation and thereby ALI. In this aim, we will
evaluate i) MEAT’s capability to deliver synergistic cytokines to the lung tissues in the pre-clinical mouse model
of ALI, and ii) the performance of MEAT in modulating the immune environment in inflamed lungs. Eventually,
we will investigate the therapeutic efficacy of MEAT in alleviating ALI and restore normal lung functions. The PI
(Early Stage Investigator) has assembled a team with complementary expertise to conduct this project. If
successful, MEAT will revolutionize how ALI is treated and opens a new area for clinical research by unlocking
unrealized applications of ALI cellular immunotherapies.

Public health relevance
PROJECT NARRATIVE Acute lung injury (ALI) and its severe form, acute respiratory distress syndrome (ARDS), is a common life- threatening disease currently with no effective pharmacological interventions; ALI/ARDS is caused by the over- activation of macrophages and infiltration of neutrophils in the inflammed lungs, and past failures of investigative interventional therapies are in part owing to their inability to resolve the overwhelming acute pulmonary inflammation. Here, we propose to engineer synergistic cytokine-coated macrophage-based immunomodulatory therapy that can efficiently target the injuried lungs, program the pulmonary macrophages and neutrophils toward anti-inflammatory status, and eventually resolve the acute pulmory inflammation. If successful, this study would lay the foundation to develop novel cellualr immunotherapies for targeted immunomodulation in ALI/ARDS which can potentially revolutionize how ALI/ARDS is pharmacologically treated.